Legal Status Exposure, Health, and Kinship Networks among Latino Immigrants

Project Summary
This project explores how immigrant legal status exposures impact the health and wellbeing of older (50+)
Latino immigrants. The unauthorized Latino foreign-born population in the US is currently aging in place,
leading to a growing number of older Latinos who experienced years of hardship throughout their adult lives
and, as older adults, are excluded from the US social safety net system. The aging of the Latino population is
thus likely accompanied by two related trends: (1) dramatic increases in the share of older Latinos without full
access to the public programs that have been shown to considerably reduce poverty and increase access to
health care among older American citizens, and (2) increased reliance by older Latinos on kinship networks –
chiefly their middle-aged children – for daily financial and health care needs. Our goal is to document these
trends and explore how they impact the health and wellbeing of older Latinos. The project has three specific
aims.
First, we will investigate how immigrant legal status exposures are related to older Latino immigrants’ health
and their access and utilization of health care. Our key innovation is to use longitudinal Health and Retirement
Survey (HRS) data that is linked to the Social Security Administration (SSA) and Medicare/Medicaid files. We
will use information from linkages to these administrative data to measure immigrants’ legal status and time
spent in each status and then model the relationship between legal status exposures and levels and
trajectories in both physical (e.g. functional limitations, allostatic load, mortality risk) and mental health (e.g.
depression, cognitive decline, Alzheimer's disease), and access/utilization of health care.
Second, we will investigate the availability and effectiveness of kinship networks of older Latinos. We will use
HRS data to explore questions related to (1) the characteristics of older Latinos' kinship networks by immigrant
legal status, and (2) the relationship between the size/characteristics of older Latino's kinship networks and
their unmet need for assistance, as well as their health and access/utilization of health care.
Third, we will develop a microsimulation model to project the size and composition of older Latino immigrants
and their kinship networks. The microsimulation will enable us to model health outcomes and the level of
kinship support for Latinos as this population ages in place over the next decade. Additionally, we will use the
model to compare the “status quo” scenario to multiple potential policy changes that would alter the level of
support for older immigrants or offer a pathway to legalization and citizenship, and impact older Latinos.
The proposed research will inform science and policy about access to care and contribute to building evidence-
based interventions for promoting health and wellbeing among the aging Latino immigrant community.

Public health relevance
Project Narrative The US foreign-born Latino population is rapidly aging and includes increasing numbers who, due to a lack of legal authorization, are excluded from the nation’s key social safety net programs for older adults. This project explores how immigrant legal status impacts the health and wellbeing of older (50+) Latinos, and the degree to which they can rely on kinship networks – chiefly their middle-aged children – for daily financial and health care needs.